Targeting Immune Inflammation in Cocaine Use Disorder: A Human Laboratory Study with Pentoxifylline

ABSTRACT
Cocaine use disorder is a persistent public health concern. Despite strides in our understanding of the
neurobiological underpinnings of cocaine addiction in preclinical models, a limited amount of research has
translated those findings to clinical populations. Such translation is crucial to identify neurobiological
disruptions that contribute to the problems posed by cocaine use disorder and to guide treatment based on
those findings. The field has long recognized the critical role of the glutamate system in cocaine use.
Specifically, a wealth of data indicate that cocaine produces profound changes in the brain glutamate system,
resulting in impaired glutamate homeostasis. Targeting this mechanism has some promise for treating cocaine
use disorder but results have been inconsistent, suggesting other strategies are needed to address brain
glutamate changes due to cocaine use. Emerging preclinical research indicates that neuroimmune signaling
mediates brain glutamate changes observed following drug exposure, but very little clinical research has
evaluated whether targeting neuroimmune signaling affects response to cocaine or if this strategy is a
promising treatment approach. Preclinical research has shown that phosphodiesterase inhibitors ameliorate
neuroimmune perturbations following stimulant use, at least in part through glutamatergic mechanisms.
Further, they selectively reduce the reinforcing effects of cocaine, the development of cocaine sensitization and
reinstatement to cocaine seeking. Most of the phosphodiesterase inhibitors tested preclinically are not
available for use in humans, however. Pentoxifylline, a xanthine derivative and phosphodiesterase inhibitor that
is used clinically to treat muscle pain in individuals with peripheral artery disease, is structurally similar to and
produces anti-inflammatory effects like the phosphodiesterase inhibitors tested preclinically. Thus, the
overarching goal of this study is to translate preclinical findings that used phosphodiesterase inhibitors to
ameliorate neuroimmune perturbations and reduce cocaine intake to the human laboratory. We seek to
demonstrate pentoxifylline reduces cocaine self-administration and abuse-related effects in individuals with
cocaine use disorder. We will also evaluate safety and tolerability of pentoxifylline and cocaine combinations
and determine whether pentoxifylline affects immune biomarkers. This research will directly translate findings
from preclinical research and provide strong clinical evidence that pentoxifylline reduces the reinforcing and
other abuse-related effects of cocaine, while also ameliorating immune perturbations associated with cocaine
use. In addition, this work has key basic science implications about neuroimmune mechanisms underlying the
pharmacodynamic effects of cocaine in humans.

Public health relevance
PROJECT NARRATIVE Cocaine produces profound changes in neuroimmune signaling and that affects downstream glutamate function, which may present a target for novel cocaine use disorder (CUD) pharmacotherapies. We propose a rigorous human laboratory study to determine whether ameliorating disrupted neuroimmune signaling through treatment with a phosphodiesterase inhibitor reduces cocaine intake and other abuse-related effects.